Administrative Core

The University of Washington Practice-Based Suicide Prevention Research Center is a multidisciplinary
collaboration to improve outcomes for suicidal adolescents and young adults in outpatient medical settings in
ways that enhance therapeutic alliance and increase self-efficacy of providers, patients and families to manage
suicide risk. The Center, led by clinical researchers who treat suicidal patients in partnership with physicians,
informatics researchers and operational experts, takes a stakeholder-based co-design approach integrating
human centered design and multi-phasic optimization to develop highly effective and efficient interventions for
the outpatient medical setting. The Administrative Core will be directed by Dr. Comtois. The Administrative Core
consists of a Team Science Core, Policy Core, and four Advisory Boards organized by an Operations Team and
overseen by a multidisciplinary Steering Committee. Central to the co-design mission of the Center is the Expert
Research Advisory Board as well as the Lived Experience, Outpatient Health Care Provider, and Policy and
Financing Advisory Boards who will advise the Center, faculty, and Collaborating Scholars from disciplines new
to suicide prevention. The Administrative Core has the following aims: (1) Facilitate communications and
coordination of Center faculty, the larger UW community and our stakeholder partners through the Coordination
Core (Operations Team and Steering Committee led by Dr. Comtois), (2) Provide mentorship and research
opportunities for Emerging and Advanced Collaborating Scholars through the R03 pilot suicide care research
program in the Team Science Core (led by Drs. Areán and Darnell), (3) Collaborate with the Zero Suicide
Institute, National Action Alliance for Suicide Prevention, and Suicide Prevention Resource Center housed in the
Education Development Center through the Policy Core (led by Dr. Julie Goldstein Grumet), and (4) Evaluate
Center progress in meeting stated goals to improve the quality of care and suicide outcomes in outpatient
medical settings across the suicide care pathway with usable, feasible, and optimized solutions (led by Dr.
Comtois and the Operations Team with consultation from Dr Areán and pediatric and family medicine physicians
and Center investigators, Drs. Laura Richardson and Ian Bennett).